Mechanistic Studies of Lantibiotic Biosynthetic and Tailoring Enzymes

Project Summary/Abstract
Lantibiotics are ribosomally synthesized and post-translationally modified peptide natural
products. The biosynthetic enzymes that convert peptide substrates into constrained
antibiotics are not well understood, especially with regards to substrate recognition.
Here, we seek to carry out biochemical, and structural biological studies on several of
these enzymes and address questions regarding substrate recognition, and substrate
tolerance. We anticipate that this work will be of use not only towards the discovery of
new compounds but to enable the production of peptide-based compounds of any
structure.

Public health relevance
Project Narrative This research plan focuses on understanding how potent antibiotics and antivirals are made from simple peptides. Knowledge gained from this proposal will allow the production of drugs and therapeutics with improved functions and properties.